Genetics, Epigenetics, and Post-translational Modifications and the Development of Ventilator Induced Lung Injury (VILI)

PROGRAM SUMMARY
Mechanical ventilation, a life-saving intervention in critically ill patients with respiratory failure due to acute
respiratory distress syndrome (ARDS), also creates excessive mechanical stress that augments lung injury, a
syndrome known as ventilator-induced lung injury (VILI). The pathobiology of VILI and ARDS share many
inflammatory features including increases in lung vascular permeability due to loss of endothelial cell (EC)
barrier integrity. Insights into VILI pathobiology have been incremental with no viable therapies realized. This PPG
intensely focuses on increasing our understanding of: i) the transcription factors that relay the effects of
excessive mechanical stress; ii) the molecular signaling pathways that lead to EC injury, including initial activation of
a mechanosensitive Ca2+-regulatory receptor, transient receptor potential cation channel subfamily V member 4
(TRPV4); iii) post translational modifications (PTMs) that influence key signaling pathways involved in VILI
responses; iv) genetic and epigenetic influences in key target genes involved in VILI responses; and v) novel
therapeutic strategies for VILI. The key novel genes that comprise the focus of each Project were identified by
our genomic–intensive approaches and selected for their capacity to contribute to a spectrum of VILI
responses from VILI-induced lung inflammation, increased vascular permeability and injury (Projects #1 and #2); to
VILI resolution with restoration of lung vascular barrier integrity (Project #3). These strategies are integrated
across our three PPG projects and represent the thematic underpinnings of this PPG. Studies will be
conducted by an outstanding group of gifted and interactive translational scientists. Project #1 will examine the NF-κB-
dependent mechanisms (including protein nitration) by which VILI downregulates expression of SOX18, a
critical lung vascular barrier-protective transcription factor (TF), and the key tight junction protein, claudin 5. The
influence of the mechanosensitive receptor, TRPV4 on mitochondrial ROS and mechanical stress-associated
TFs such as HIF2α will be explored. Project #2 will extend novel insights regarding the critical role of secreted
extracellular NAMPT (eNAMPT), a nicotinamide phosphoribosyltransferase, in VILI and ARDS. Excessive
mechanical stress induces NAMPT expression and eNAMPT ligates TLR4 (Toll-like receptor 4) to induce NF-κB
signaling and inflammatory lung injury. Project #2 will interrogate novel mechanisms of NAMPT secretion, the
influence of NAMPT/TLR4 SNPs, and NAMPT and TLR4 as therapeutic targets. Project #3 will interrogate
genetic and epigenetic regulation of mechanical stress-mediated sphingosine 1-phosphate receptor expression
(S1PR1, S1PR3) and the role of VILI-induced nitration of Rac1 and RhoA GTPases in lung vascular barrier
regulation. The synergy derived from the interaction between individual Projects, as well as with our scientific
Cores, with enviable expertise in molecular biology (B), genetic epidemiology (B), pre-clinical models of
disease (C), and protein chemistry & Biophyics (D), will advance our programmatic approaches and promote the
development of novel, individualized therapies to attenuate VILI especially in populations at risk for ARDS.

Public health relevance
RELEVANCE: This PPG application is focused on the critical role of mechanical ventilation, a life-saving intervention in critically ill patients with respiratory failure, in creating excessive mechanical stress that directly augments lung injury, a syndrome known as ventilator-induced lung injury (VILI). This PPG intensely focuses on understanding: i) the transcription factors that relay the effects of excessive mechanical stress; ii) PTMs that influence key signaling pathways involved in VILI responses; iii) genetic and epigenetic influences in key target genes involved in VILI responses; and iv) novel therapeutic strategies for VILI. Elucidating the contributions of genetics, epigenetics and PTMs to VILI pathobiology, will enhance therapeutic targeting and increase our knowledge of the genetic basis for ARDS health disparities.